Multi-organ Inflammatory Responses after Burn Trauma

Burn is a form of traumatic injury that affects more than just the skin and can cause damage to multiple organ
systems. Of the one million people per year who suffer burn injuries in the United States, 40,000 are admitted
to hospitals. Remarkably, about half of those patients are intoxicated at the time of injury. Burn patients who
were intoxicated when they sustained their injuries have increased morbidity and mortality compared to burn
patients who had not been drinking. The lung is the most frequent organ to fail after a remote injury such as
cutaneous burn, with 45% of burn patients showing some form of lung damage even in the absence of
inhalation injury. Pneumonia and acute respiratory distress syndrome (ARDS) are among the major
complications seen in intoxicated burn patients. However, little is known about the mechanism by which
alcohol intoxication modulates systemic inflammatory responses that lead to excessive pulmonary
inflammation and increased susceptibility to lung infection and damage in burn victims. Evidence suggests that
reduced integrity of the epithelial barrier of the gut secondary to burn injury plays a critical role in this process.
Burn trauma and alcohol intoxication independently reduce the intestinal barrier integrity by altering the
localization of epithelial tight junction proteins. Following the dual insult of alcohol intoxication and burn injury,
the responses are compounded (additively, if not synergistically). The result is a more dramatic release of
bacterial products and endotoxins into the portal and systemic circulation, triggering the so-called “cytokine
storm” characteristic of injury-induced systemic inflammation. From these observations, we hypothesize that
after burn injury, 1) intestinal dysfunction, including a breach in the integrity of the intestinal epithelial
barrier, mediates the observed multi-organ complications, 2) that these changes can be monitored by
measuring biomarkers of intestinal damage and inflammation in the blood, and that 3) gut-directed
therapies will restore intestinal and systemic homeostasis improving the function of distal organs
such as the lung. To test this hypothesis, first, in Aim 1, we will examine whether intestinal barrier
dysregulation in the setting of alcohol intoxication and burn injury precedes pulmonary inflammation and if the
intestinal barrier changes can be followed over time using a panel of blood-borne biomarkers. In Aim 2, we will
investigate whether restoration of intestinal barrier integrity attenuates systemic and pulmonary indices of
inflammation in our mouse model of alcohol intoxication and burn injury and whether repairing the intestinal
barrier improves the pulmonary response to an infection. Lastly, in Aim 3, we will study burn patients, with and
without recent alcohol intoxication, longitudinally to determine if the superimposed impact of burn injury with
alcohol abuse alters intestinal barrier dysregulation to a greater extent than burn or alcohol alone. Moreover,
we will see if there is a relationship between intestinal dysregulation and systemic and pulmonary
inflammation. In this aim, we will also assess circulating biomarkers of inflammation and intestinal barrier
damage and determine if they can be used to predict acute hypoxic respiratory failure and poor responses
following pulmonary infections. Taken together, these studies will expand on the limited knowledge of how
alcohol intoxication alters the gut intestinal barrier in the context of burn trauma. Studies targeting the gut in our
animal model can serve as the first step in developing novel therapeutic interventions for the treatment of
patients with burn injuries in active military and veteran populations. Moreover, this work has implications that
extend beyond burn injury as intestinal barrier dysfunction may play a role in non-burn injury related disorders
ranging from traumatic brain injury to post-traumatic stress disorder.

Public health relevance
Trauma, including burn injury, is a major cause of morbidity and mortality in the United States accounting for millions of disabling injuries, costing over $130 billion annually. Damaging more than just the skin, burn injuries can lead to multi-organ failure, often stemming from a breach in the intestinal barrier, which releases bacteria and bacterial products into the bloodstream. Excessive inflammation resulting from the injury itself and from a “leaky gut” can damage other tissues including the lungs. Surprisingly, about 50% of adult burn patients consumed alcohol prior to injury. Both intoxication and burn independently increase gut permeability and the combined insult triggers heightened inflammation, yet paradoxically renders the host susceptible to opportunistic pathogens which can be fatal. Elucidating the contribution of the gut to multi-organ responses after burn trauma has direct applicability to the veteran population. Given that alcohol abuse is a common problem in veterans, understanding how intoxication worsens outcome after burn is of high clinical significance.